Protecting the kidney from cisplatin induced injury and progression to chronic kidney disease

This proposal is in response to PAR-21-329 “Clinical Characterization of Cancer Therapy-Induced Adverse
Sequelae and Mechanism Based Interventional Strategies.” Cisplatin is prescribed as a first-line treatment in
nearly 20% of tumor chemotherapies, but efficacy is hindered by dose-dependent nephrotoxicity. Thirty percent
of cancer patients receiving cisplatin develop acute kidney injury (AKI), a rapid decline in kidney function. AKI
not only contributes to substantial morbidity, but also dramatically increases risk of chronic kidney disease
(CKD), a leading cause of mortality worldwide
. There are no FDA-approved drugs for the treatment of cisplatin-
induced AKI-CKD. The ultimate goal of this work is to protect the kidney from cisplatin-induced AKI and
prevent its progression to CKD to improve cancer cure rates and enhance quality of life for cancer survivors.
This proposal employs a new more clinically relevant model of cisplatin-induced AKI-CKD that was
developed in our laboratories, termed
Repeated Low Dose Cisplatin (RLDC) that involves weekly low doses of
cisplatin over four weeks
; cancer is included in the model as an important co-morbidity. This RLDC model
induces kidney injury, fibrosis, and CKD (RLDC-AKI-CKD) reminiscent of the clinical condition. Data indicate
that the presence of a distant tumor adversely alters kidney function and physiology independently, exacerbates
RLDC-AKI-CKD, and, perhaps most importantly, compromises the effect of agents previously shown to be
nephroprotective in non-cancer bearing animals treated with RLDC. These data indicate the existence of a
previously unappreciated cancer-kidney crosstalk and provide rationale for further investigation into
underlying mechanisms of RLDC-AKI-CKD.
the
Our preliminary data indicate a mechanistic role for kidney infiltrating and resident macrophages
(KIRMs) in the cancer-kidney crosstalk and RLDC-AKI-CKD. Cancer-induced KIRM accumulation leads to an
epithelial to mesenchymal transition that involves loss of key epithelial proximal tubule components including
the sodium glucose co-transporter 2 (SGLT2) and the 5-HT1F receptor; FDA approved drugs that inhibit SGLT2
or act as agonists of the 5-HT1F receptor are protective in RLDC models without cancer, but are entirely
ineffective in RLDC models that include cancer due to the KIRM-induced PT EMT and resulting loss of drug
targets. This proposal tests the hypothesis that distant tumors increase KIRMs to induce PT EMT and fibrosis,
thereby sensitizing the kidney to RLDC-AKI-CKD; depletion of KIRMs will restore the efficacy of drugs that
protect the kidney from RLDC-AKI-CKD. We will (1) determine the role and mechanism of specific KIRM
subpopulations in the cancer-kidney crosstalk and RLDC and (2) determine if therapeutic targeting of KIRMs
restores the efficacy of nephroprotectants in RLDC-AKI-CKD. These studies will provide essential translational
data for development of therapies to prevent long term cancer and chemotherapy-induced kidney sequalae.

Public health relevance
Protecting the kidney from cisplatin induced injury and progression to chronic kidney disease Many cancer patients have decreased kidney function prior to initiation of cancer treatment and following treatment with cisplatin up to 30% of patients will suffer acute kidney injury. We have found that the presence of a distal lung tumor is sufficient to alter kidney physiology and establish a pre-fibrotic niche within the kidney. Herein, we will examine the mechanisms of cancer and cisplatin induced kidney injury and test novel therapeutics to block kidney injury and progression to chronic kidney disease.